Global studies into the Genetic Architecture of the Brain's White Matter Network through Harmonized and Coordinated Analyses in the ENIGMA-Consortium

ABSTRACT
White matter (WM) circuitry is the basis for neuronal communication in the human brain and exhibits robust
abnormalities in all major psychiatric, neurological, and developmental conditions. The ENIGMA consortium has
already performed the largest, most well-powered coordinated studies of WM microstructural variability within
and across several major mental disorders and illnesses. We have already discovered common patterns of
deficits in our most highly powered, and internationally representative studies of severe mental illnesses to date,
including schizophrenia (SCZ), bipolar disorder (BD), and major depressive disorder (MDD). The overlap in the
patterns of microstructural variation in these disorders also correlate with the overlap in genetic risk suggested
by large scale GWAS. These emerging findings within the ENIGMA consortium motivate a highly-powered,
rigorous, and in-depth study of disease and genetic effects on WM tracts and circuits implicated in severe mental
illnesses. Here we launch an initiative that unites leaders in the fields of neuroimaging harmonization and
analysis, diffusion connectivity, psychiatry, psychiatric genetics, statistical genetics, neuroimaging genetics,
workflow automation, and AI and distributed data science. Our proposed work will extend the collaborative study
of mapping brain-imaging biomarkers and the variability that drives underlying vulnerability to risk of mental
illness. All our findings will be made publicly available, as in all prior ENIGMA studies. Here we extend methods
for the public distribution and dissemination of findings through NeuroDISK - an ontologically integrated, user-
friendly platform, for user-driven sub-analyses based on cohort level meta-data. This innovative framework
enables continuous data integration and updating of findings. In our Specific Aims, our multidisciplinary and
highly productive team of investigators will: 1) perform a global coordinated GWAS of microstructure metrics in
over 100,000 individuals of all ages scanned with diffusion MRI in a discovery and replication framework; 2)
distribute a novel AI-driven protocol to extract and quality control the midsagittal corpus callosum metrics from
the more commonly collected, T1-weighted structural MRIs, to map and harmonize developmental trajectories
of callosal maturation and degeneration across the lifespan; we will accommodate MRI data of research and
clinical quality, and identifying genetic architecture for callosal thickness, area, and curvature; 3) constructing an
integrated ENIGMA-DSI Studio pipeline offering high-throughput tractography and fiber analytic methods on the
DSI-Studio software to identify structural dysconnectivity in ENIGMA working groups on SCZ, BD, MDD; 4)
distribute and disseminate publicly available, containerized tractography and fiber analytic protocols with image
acquisition specific considerations, and means for continuous data integration and analyses in our novel
NeuroDISK framework.

Public health relevance
NARRATIVE White matter circuitry is the basis for neuronal communication in the human brain and has been found to be abnormal in all major psychiatric, neurological, and developmental conditions. Our proposed work significantly extends the worldwide ENIGMA (Enhancing NeuroImaging Genetics through Meta Analysis) consortium by mapping novel white matter circuitry biomarkers and the variability that drives underlying risk for mental illness. We will coordinate global genome-wide investigations into the genomic architecture of white matter structural and microstructural metrics in over 100,000 individuals of all ages in a discovery/replication framework and further, construct and disseminate an integrated ENIGMA DSI Studio pipeline offering coordinated, high- throughput, tractography and fiber analytic methods to identify structural dysconnectivity in ENIGMA working groups on severe mental illnesses.